Bioinformatics Core

Project Summary – Bioinformatics Core
The Bioinformatics Core, will conduct bioinformatics and statistical analyses of data generated by Projects
and Cores to address research hypotheses defined in the project-specific proposals as well as perform
integrative analyses in order to combine data from all experiments. The Core will provide central storage, data
management, and information security for generated raw and processed high-throughput data within the
PTDC. The Core will assist with preparation and writing of final reports, abstracts, manuscripts, and future
research proposals. During the span of the Research Program, Bioinformatics Core will ensure a timely
progress tracking of PDX trials and sharing of generated results between members of PTDC.